ANTIPNEUMOCYSTICS &ZIDOVUDINE PREVENTION OF INFECTIONS IN AIDS PTS--ACTG 081

A randomized trial of three anti-pneumocystis agents plus Zidovudine for the primary prevention of serious infections in patients with advanced HIV infection.